IND-enabling toxicology studies to reach IND approval for a proprietary biologic to treat oral mucositis in cancer patients

Summary
Oral mucositis, a severe oral ulceration, is a common toxic effect of radio- or chemoradio-therapy (RT or CRT)
and a limiting factor to using the optimal dose of radiation for effective cancer treatment. Intensity modulated RT
(IMRT) and stereotactic Body RT (SBRT) spare more normal tissues and lessen chronic side effects, but not
oral mucosa in head and neck cancer patients. To date, Palifermin, a protein derived from keratinocyte growth
factor, is the only targeted therapy approved by the Food and Drug Administration (FDA) for preventing oral
mucositis in patients with hematopoietic malignancy followed by bone marrow transplant (4% of the at-risk
population), but it has no effect on existing mucositis. Allander Biotechnologies has developed a proprietary
biologic that shows prophylactic and therapeutic effects on radiation-induced oral mucositis in mice and dogs
upon topical application to oral mucosa. Our biologic possesses multiple functions needed for oral mucositis
healing. Under the previous SBIR Phase II funding supporting Allander’s drug development, we have 1) identified
the lead drug and formulated it as oral gel; established the manufacture platform and quality control (QC) panels
ready to be implemented for quality assurance (QA) for certified Good Manufacture Practice (cGMP); 2)
established efficacy dose range in dogs that be scaled to the treatment dose in human oral mucositis patients;
3) defined pharmacodynamics (PD) based on mechanisms of actions; 4) de-risked toxicity and oncogenic
potential; 5) developed pharmacokinetics (PK) PK/Toxicokinetic (TK) and immunogenic assays needed for
toxicology studies and clinical trial. Under this Commercialization Readiness Program (CRP) application, we will:
a) manufacture our drug under Good Engineering Practice (GEP) conditions to supply the Good Lab Practice
(GLP) toxicology studies; b) perform in-use dose formulation tests of our drug in toxicology studies and finalize
dose-formulation analyses to be used in clinical trial; c) perform systemic GLP toxicology studies in small and
large animal species with the safety data to support future maximum clinical dose. The milestones under this
funding are to apply for Investigational New Drug (IND) of our drug and receive approval from the FDA to initiate
our Phase I clinical trial. Our ultimate goal is to complete the first-in-human Phase I trial and initiate Phase II/III
trials afterwards and file a New Drug Application (NDA) after completing clinical trials.

Public health relevance
Narrative Oral mucositis, a painful oral ulceration, is one of the most debilitating toxicities of cancer therapy. Our proprietary drug targets multiple processes of oral mucositis thus delivering a more effective oral mucositis treatment in cancer patients. Our proposed studies will allow us to obtain IND approval by the FDA to initiate the first-in- human clinical trial after completion of this grant, thus bring a new therapy to clinic. Meeting this unmet need will improve cancer patient outcomes and quality of life by enabling optimal RT regimens, reducing pain and preventing other sequelae.